Targeting Grainyhead-Like 2 Suppresses Entry Factors of SARS-CoV-2 in Epithelial Cells of Oral Mucosa.

Abstract
The long-term goal of our research is to develop effective therapies against SARS-CoV-2-elicited disease
Covid-19. SARS-CoV-2 spike (S) protein binds to its cognate receptor, angiotensin-converting enzyme 2
(ACE2), and in concert with host proteases, principally transmembrane serine proteases (TMPRSSs),
promotes cellular entry. Co-expressions of these viral entry factors are found in the epithelial cells of
many organs, including oral mucosa. Recently, oral mucosa has been found to be a potentially high-risk
route of SARS-CoV-2 infection. GRHL2, as a transcriptional factor, modulates epithelial gene expression
and plasticity through multiple signaling pathways. ACE2 and TMPRSS2 are strongly expressed in
epithelial cells, coinciding with the pattern of GRHL2 expression in oral mucosa. GRHL2 regulates ACE2
and TMPRSS2 expression in normal human oral keratinocytes (NHOK). Ectopic expression of GRHL2
induces ACE2 and TMPRSSs expression, while knockdown of GRHL2 leads to decreased levels of these
entry factors. ACE2 is an interferon-stimulated gene. IFN-α activates ACE2 expression in part through
regulating GRHL2. Small-molecule inhibitors of GRHL2 suppress viral entry factor expression in NHOK.
ACE2 and TMPRSS2 are widely expressed in oral mucosal epithelium, knockout of GRHL2 leads to
suppression of ACE2 and TMPRSS2 expression in vivo. These findings indicate that GRHL2 is required
for ACE2 and TMPRSS expression in NHOK cultured in vitro and oral mucosal epithelium in vivo. Based
on these data, we hypothesize that targeting GRHL2 inhibits SARS-CoV-2 transmission into oral
mucosal epithelium through regulating viral entry factor expression. This novel hypothesis will be
tested by examining the molecular mechanism underlying GRHL2 regulates expression of SARS-CoV-2
entry factors (ACE2 and TMPRSSs) in oral mucosal epithelial cells. Analysis of variance methods will be
used to compare means of these gene expression levels. We will also generate a pseudotyped virus in
which vesicular stomatitis virus (VSV) green fluorescent protein (GFP) reporter virus expressing SARS-
CoV-2 S in replacement of native glycoprotein. Utilizing this chimeric virus, a high throughput assay will
be developed to screen GRHL2 inhibitors, which possess the potentials to abrogate SARS-CoV-2 virus
infection into oral mucosal epithelium.

Public health relevance
Relevance to Public Health Statement The proposed research will lead to understanding the regulatory mechanism of Grainyhead-like 2 (GRHL2) in expression of entry factors of SARS-CoV-2 in the epithelium of oral mucosa. Outcomes of this project may shed light on the mitigation approaches to reduce SARS-CoV-2 infectivity through oral cavity and eliminate this virus-mediated multiple organ dysfunctions, thereby enhancing public oral and systemic health.